Interstate Seafood Seminar Annual Meeting 2015

Project Summary/Abstract An important aspect to this annual meeting is the planning committee comprised of representatives from the regulatory community and academic partners. The planning meeting is typically held in January. At the planning stage, topics are discussed and chosen based on relevance to seafood safety, water quality, seafood HACCP, etc. Lately the important issue of reducing the risk of Vibrio in oysters, a naturally occurring pathogen, has been one of the most common concerns. Topics for this issue are clinical, environmental, and at times very technical. Laboratory methods are also an import topic of concern. Input is gathered from all representatives and FDA's participation plays an important role in the planning stages. The host state is responsible selecting a meeting site, announcing dates and location, registration, any agreements with the hotel for meeting spaces, and for finalizing the agenda topics and securing the speakers for the meeting. This responsibility rotates between the participating states (Virginia, North Carolina, Maryland, New Jersey, and Delaware). The Interstate Seafood Seminar brings together regulators, public health professionals, researchers and industry in an informal setting. Seafood safety such as using best management practices and Seafood HACCP is everyone's responsibility. Seafood safety is very important in preventing food borne illnesses and providing cost savings to consumers. This annual meeting provides an unprecedented opportunity for participants to network with other regulators, both federal and state, in a cooperative and informative setting. The opportunity for researchers to present and discuss their latest findings with regulators lays the framework to assess needs and how the research can be utilized in a regulatory or industrial setting while serving to improve seafood safety. This venue promotes informal discussion and since it is regional in nature provides an opportunity for many participants that may not get an opportunity to participate in larger, formal national meetings. Attendees include regional State and local regulators, federal partners (FDA, EPA, NOAA), industry, and academics. The purpose of this application is to facilitate participation from State partners whose attendance might otherwise be denied due to budget constraints.

Public health relevance
Project Narrative One central aspect of the Interstate Seafood Seminar is bringing together professionals in an informal setting to discuss topics of significance related to the most current public health issues. This meeting provides this venue and has been in existence since 1949. Seafood safety continues to be relevant today and a key issue to regulators and consumers. The ISS is a seminar that has its focus on the seafood industry in the United States. From harvest to consumer, from ocean bound states to inland states, all topics are discussed. Attendees include - government regulators, academia, industry, and anyone who regulates, distributes, sells, produces or processes seafood in the United States. In this ever growing industry, there is an overabundance of regulations to assure consumers that seafood is safe to eat. Attendees will continue to be informed on the foremost issues related to new and innovative technology, Country of Origin Labeling requirements, pathogens of concern, seafood at retail initiatives, updates on new regulations, FDA initiatives and more. Topics discussed at the Interstate Seafood Seminar will emphasize current hot-button issues such as the detection of infectious norovirus within oysters, Dinophysis in Maryland's Coastal Bays, update on time and temperature regulations, aquaculture, beach research, resource management and a myriad of shellfish and seafood resource issues. Attendees include regional State and local regulators, federal partners (FDA, EPA, NOAA), industry, and academics. This regional meeting is designed to reach a broad audience. The purpose of this application is to maintain a base participation and to facilitate participation from partners whose attendance might otherwise be denied due to budget constraints.